Adaptation of a digital health HIV prevention intervention for Black heterosexual couples in New York State

ABSTRACT / SUMMARY
Current HIV/STI prevention interventions for Black heterosexual / opposite-sex (BHOS) couples in the
US require an in-person modality and focus on specific subgroups (sero-doscordant, substance using). Digital
health interventions (DHIs) may provide one solution to expand access to tailored, couples-based HIV/STI
prevention-care interventions that appeal to a wide variety of Black heterosexual / opposite-sex (BHOS)
couples in the U.S. with varying vulnerabilities to HIV and other STIs.
One couples-based DHI has reduced cisgender male couples’ susceptibility to HIV and other STIs. The
DHI used a hybrid format with individuals first completing a sequence of pre-determined modules (i.e., HIV/STI
education, instructional videos, a searchable sexual health resources database, activities including an
agreement builder) followed by completing the sequence jointly with their partner, and then ending with a
finalized, comprehensive sexual agreement containing HIV/STI prevention items. To examine the acceptability
of this theoretically-driven, couples-based DHI for HIV/STI prevention, we conducted a multi-method pilot
project with 28 BHOS couples in New York State. BHOS couples reported high intervention acceptability
(96%), and qualitative dyadic content and thematic analysis revealed explicit recommendations to enhance
intervention relevancy for adapting the DHI to meet their specific relationship and sexual health needs.
Given these preliminary findings, we propose to conduct a novel, 3-year mixed method study guided by
the Couples Interdependence Theory and the ADAPT-ITT model to adapt and pilot-test this DHI to meet the
needs of BHOS couples. Dyadic data will be collected via: a) quantitative assessments at baseline, month 3
and 6; b) HIV/STI screening at baseline and month 6; c) 7 different paradata outputs (intervention use); d)
individual exit interviews at month 6. Our specific aims are: Aim 1: Adapt the intervention for BHOS couples
using the APAPT-ITT model with human-centered design. Aim 2: Conduct a 6-month pilot RCT with 60 BHOS
couples using a 2:2 block random allocation approach (intervention vs. 3-month, delayed control), stratified by
dyad HIV serostatus (i.e. serodiscordant, seroconcordant). Feasibility will measure enrollment and retention
rates. Acceptability will leverage mixed methods from 3 data sources: qualitative - to contextualize intervention
engagement; paradata - to describe intervention use over time; quantitative - to assess usability, sexual health
behavior and general wellness. Aim 3: Examine preliminary intervention impact: 1) primary outcomes (mutual
HIV/STI awareness; creation/adherence to a tailored relationship agreement, uptake/adherence of evidence-
based biomedical strategies); 2) secondary outcomes (Improvements in relationship dynamics including
communication). Impact will be assessed via couples’ outcomes over time, between trial arms, and for all
couples. This study has high public health significance complemented with rigor and scientific premise to
address a critical gap in couples-based interventions.

Public health relevance
NARRATIVE This R34 study has high Public Health significance, is complemented with rigor and scientific premise and uses a human-centered design, mixed methods and the ADAPT-ITT framework to address a critical gap in HIV/STI prevention-care. This study employs a 6-month pilot RCT to assess individual- and couple-level feasibility, acceptability and preliminary impact of a couples-based, digital health intervention (DHI) for improving HIV/STI prevention-care with a new population - Black heterosexual/opposite sex (BHOS) couples residing in New York State. It is expected that findings will reveal the feasibility, acceptability, and preliminary impact of the adapted DHI on couples’ primary (and secondary) sexual health outcomes, as well as how best to apply these findings in a larger, adequately powered trial (R01).